Pilot Projects Program

Despite recent improvements in some area of health, Oklahoma continues to have high rates of tobacco and
substance use, obesity, cancer and cardiovascular deaths, arthritis disability and poor overall health choices.
The mission of the OSCTR Pilot Projects Program is to accelerate discoveries into Oklahoma’s health priorities
by fostering innovative and collaborative clinical and translational research (CTR) projects, leading to nationally
and federally funded independent research programs. Our program has funded 50 pilot projects with >50%
female and 20% of these PIs from under-represented minority populations. These pilot recipients have been
immensely successful garnering more than $90M of PI-level extramural funding to these new investigators,
including more than $10M annual federal funding. This program provides pilot project funding (Aim 1),
coordinates infrastructure support and mentoring for pilot investigators (Aim 2), and identifies promising but
unfunded junior investigators for additional mentoring (Aim 3). This strategy is built on the hypothesis that
providing junior investigators with CTR funding, infrastructure, and mentorship will coalesce a new generation
of well-trained, well-funded CTR scientists equipped to translate scientific discoveries into improved clinical
care and patient well-being. The Pilot program prioritizes research that addresses prominent health issues in
Oklahoma and other IDeA states. Building on early successes and being responsive to needs identified by past
pilots, EAC and Evaluation Core feedback, the program is increasing its administrative support to Pilot PIs to
provide more mentoring in grant management skills. It is continuing to offer two award types: CTR Pilot Awards
provide 12 months of funding for at least five novel research projects per year; Pilot Sustainability Bridge
Awards can provide 6 additional months of funding for up to 2 pilot recipients per year to address the need for
interim support while analyzing, publishing, and seeking extramural funding for their projects. We encourage
Pilot projects that support the unique needs of our partners with partnerships that include non-academic
institutions, such as tribal institutions, community development agencies, county health improvement
organizations, and primary care providers. In addition to these OSCTR-funded awards, the program leverages
other local funding programs when possible to provide larger or additional awards in each category. Beyond
providing financial support, the program had demonstrably demonstrated that it provides an environment that
nurtures the success of these junior investigators. Annual Pilot initiation meetings will introduce awardees to
the OSCTR Cores, Directors, and other awardees. Throughout the award, investigators will receive structured
mentoring (Professional Development Core) and training in scientific writing to foster career development and
growth toward independence, including peer mentoring through proposal critique opportunities. The program
continues to assist current and past awardees, as well as promising but unfunded applicants, to identify
additional funding sources and develop a strategy for securing independent, national funding.